IGF::OT::IGF Task Order 73: : Cancer Intervention and Surveillance Modeling Network (CISNET) 2017 Mid-Year Meeting

Cancer Intervention and Surveillance Modeling Network (CISNET) 2017 Mid-Year Meeting Support